FY25. SBIR TOPIC 167 PHASE II: ULTRAPORTABLE LAB-ON-A-CHIP BIOSENSOR SYSTEM FOR RAPID POSTMORTEM TOXICOLOGY. PERIOD OF PERFORMANCE: 9/01/25-8/31/27

This contract supports work that is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.